ENVIRONMENTAL ENRICHMENT FOR NONHUMAN PRIMATES

This application requests support by the American Society of Primatologists for a major, full-day symposium on "Environmental enrichment for nonhuman primates" to be held in conjunction with the 11th annual meeting of the Society, on June 2-6, 1988 jointly at Loyola and Tulane Universities in New Orleans. The costs requested are for speaker costs (national and international) and the preparation of a volume of the presentations which, the applicants anticipate, will become the standard reference text for research workers engaged in the study and maintenance of nonhuman primates in biomedical and behavioral research, zoological parks or research studies in the field. The symposium will consist of introductory presentations relative to all species of primates and cover such subjects as environmental needs of primates in captivity, physiological consequences of social stress (dominance and submission), behavioral responses to environmental change, environmental engineering and primate welfare, nutritional enrichment, special problems of puberty and adolescence, pregnancy and mother-infant interactions. During the second half of the symposium, two simultaneous sessions will be held to deal with specifics of environmental enrichment of two major classes of primates. One session will relate to the larger great apes, especially the chimpanzee. The second session will relate to smaller but common new and old world primates as well as prosimians. An organizational committee has been established. General topics have been selected and progress is underway to further refine the symposium and to finalize the program. The determination to hold this symposium is based on two highly successful smaller symposia held last year at the XIth Congress of the International Primatological Society and at the 10th annual meeting of the American Society of Primatologists at Madison, WI. Additionally, growing interest in the subject and the pending APHIS regulation changes relating to the psychological well being of primates have made the subject of intense interest to all who use and study these important animals.